Natural variation in synaptic neurotransmission of the lateral line in the blind Mexican cavefish

Project Summary
Our goal is to understand the mechanisms underlying sensory system compensations during
embryonic development. To address this, we turn to the Mexican tetra, Astyanax mexicanus, a
fish species comprised of surface fish with eyes, and blind cavefish with non-visual sensory
system compensations. The mechanosensory hair cell-containing lateral line is one of these
compensating systems. Cavefish have an expanded lateral line that compensated for embryonic
eye degeneration, but the developmental mechanisms underlying this are unclear. Further, the
cavefish lateral line lost the function of its efferent inhibition, potentially explaining enhancements
in hair cell neurotransmission compared to surface fish. Our central hypothesis is that eye
degeneration directly contributes to expansion of the lateral line in blind cavefish, through changes
in synaptic inhibition of hair cells during embryonic development. We designed 2 aims to directly
test this hypothesis. In aim 1, we will compare the development of the lateral line between larval
populations of A. mexicanus through immunohistochemistry to identify the embryonic origin of
supernumerary neuromasts in blind cavefish. Using confocal imaging, we will quantify cellular
components of the developing lateral line, including synaptic elements of hair cells in larval
surface fish and cavefish. In aim 2, we will determine if expansions of the lateral line share
developmental underpinnings with eye degeneration. We propose lens-ablations in surface fish
embryos to examine the effects on lateral line development. Next, we will perform lens-
transplantations between surface fish and cavefish embryos prior to eye degeneration in cavefish,
to examine if lateral line phenotypes are swapped between populations. Finally, we will perform
trait correlations between lateral line and eye phenotypes in larval surface fish-cavefish F2 hybrids
to find if development of both sensory systems share genetic underpinnings. We expect that
lateral line phenotypes are associated to eye development, meaning eye degeneration precedes
and contributes to lateral line expansions in cavefish, putatively through synaptic changes, and
that these traits are governed by the same set of genes. Towards completion of this project, I will
receive mentorship from Dr. Johanna Kowalko, a leading scientist that applied functional genetics
to study eye regression in cavefish, and Dr. Katie Kindt, a pioneer in the field of hair cell synaptic
development in zebrafish. In alignment with the goals of the R16, I will actively involve 2 graduate
students and a team of undergraduates that will directly contribute to all experiments towards
completion of this project in the University of Puerto Rico, Medical Sciences Campus.

Public health relevance
Project Narrative Sensory systems play a critical role in human health, serving as the primary interface with the environment. This proposal aims to investigate how congenital visual impairments lead to compensations in other sensory systems, providing insights into potential treatments for individuals with sensory impairments.